Clinical Research and Academic Success in Obstetrics & Gynecology

PROJECT SUMMARY
Diseases and disorders in Obstetrics and Gynecology (OBGYN) and women’s health have a
profound impact on public health and families in the U.S. and around the globe. In addition,
many of these healthcare issues disproportionately impact poor and minoritized women and
pregnant people. For example, infant and maternal morbidity and mortality, preterm birth, low
birth weight, unintended pregnancy, sexually transmitted infections, infertility, and cervical
cancer all impact impoverished persons and persons of color to a greater extent than white and
more affluent individuals. Unfortunately, there is a lack of well-trained OBGYN clinical
investigators to address these important public health problems. The purpose of this R13
application is to provide support for 10 conferences/courses (twice per year for 5 years) to train
junior OBGYN investigators in clinical research design, biostatistics, ethical conduct of research,
and academic success (e.g., publishing, grant writing, promotions, etc.). The specific aims of
this application are to: 1) provide support for a diverse group of faculty that will create an
educational, interactive, and inspiring course in clinical research design and academic success
in OBGYN and women’s health research; 2) recruit promising and diverse junior faculty and
fellows in OBGYN who will attend the course, bring back valuable insights to their departments,
mentor fellows, OBGYN residents and medical students interested in OBGYN research, and
advance cutting edge science that will ultimately improve OBGYN and women’s health; and 3)
evaluate and improve this course through iterative approach with feedback from participants
and by tracking attendees over time to assess “success.” Success with be defined by tracking
academic metrics such as the number of peer-reviewed publications, grants submitted and
obtained, and academic advancement (e.g., promotion) and awards. We will also track our
recruitment of diverse faculty and conference attendees. The course will be innovative as it will
begin with virtual meetings to establish a baseline knowledge base and to tailor the course itself
to attendees and will follow participants over 18-24 months to assess success. It will stimulate
new ideas through facilitated brainstorming sessions, group discussions, scheduled, intentional
one-on-one interactions (mentoring sessions); The ultimate goal of this course is to train a new
and inspired group of new OBGYN investigators who will be poised to advance the health of
women and pregnant people in the U.S. and abroad.

Public health relevance
PROJECT NARRATIVE Clinical research training in Obstetrics and Gynecology (OBGYN) has fallen behind other disciplines; however, the challenging problems in OBGYN and women’s health are vitally important to public health. Led by a diverse group of faculty, this four-day clinical research training course will provide a strong foundation in research methodology and valuable learning and networking opportunities for junior faculty and fellows in OBGYN. Ultimately, the course will create a cadre of junior investigators who will help improve the health of women and pregnant people for years to come.